RESEARCH PROTOCOLS AND ALCOHOL TREATMENT OUTCOMES

Clinical trials of alcohol treatments have occurred at increasing frequency and levels of sophistication. Such research has contributed significantly to the advancement of knowledge regarding treatment processes and outcomes. However, the generalizability of the data may be question because of possible subject reactivity to the research process. The long- term goal of the proposed research is to enhance the utility of clinical trials of alcohol treatment to clinical practices. The purpose of this study is to investigate reactivity experimentally. The propose of this study is to investigate reactivity experimentally. The purpose of this study is to investigate reactivity experimentally. The proposed research is aimed at determining the independent contribution of two specific components of the research assessment interview, frequency and comprehensiveness, to subject treatment participation and post-treatment drinking behaviors. The results of this study will have implications for the methodology used in clinical trials with ultimate consequences for clinical practice. The specific questions to be researched are: Does research participation affect subject treatment retention? And, Do research follow-up assessment interviews contribute to the inducement and maintenance of behavior change for individuals treated for alcohol problems?